Diamond quantum sensor for magnetoencephalography

Imaging the currents in the brain is critical to our understanding of brain function and is an important technique
to study neurological disorders such as traumatic brain injury, schizophrenia, and epilepsy. The gold standard
for high spatial resolution of human visual brain activity is fMRI, but development of lower-cost brain imaging
systems is needed to expand access. Electroencephalography (EEG) is a common method of brain functional
imaging, involving the placement of arrays of electrodes on or through the scalp. However, electrical signals
can be distorted as they propagate through the head, obscuring signal interpretation.
Magnetoencephalography (MEG) is a promising method of functional brain imaging that has seen a recent
surge of interest. MEG directly images the unattenuated magnetic fields produced by neuronal currents via a
helmet sensor-array. However, magnetic fields produced by the brain are extremely faint. For decades, MEG
has required ultra-sensitive magnetic field measurements enabled by SQUIDs to noninvasively detect brain
activity. However SQUIDs require cryogenic operation, resulting in a cm-scale standoff that limits the
achievable spatial resolution and signal strength. More recently, optically-pumped magnetometers (OPMs)
have been introduced that have a comparable sensitivity to SQUIDs. However, OPMs must be heated to ~150o
C, requiring additional standoff to avoid patient discomfort. They also can only operate in a zero-magnetic field
environment, which can typically only be accommodated by costly magnetically-shielded rooms in elite
hospitals, and they have a limited dynamic range of ~5 nanotesla.
Diamond quantum sensors. We are developing miniature magnetic field diamond quantum sensors that
operate at ambient temperatures and in Earth’s magnetic field. They feature a dynamic range of ~1000 nT and
a sensor-scalp standoff of ~1 mm, which offers advantages in both signal strength and spatial resolution
compared to SQUIDs and OPMs. Their ability to operate in Earth’s magnetic field potentially removes the need
of a magnetically shielded environment, expanding MEG access beyond elite hospitals. Our sensor offers
these advantages by incorporating three innovations in diamond quantum sensing technology:
i) Magnetic flux concentrators. Our team has recently discovered a method of enhancing the magnetic
sensitivity of diamond quantum sensors based on ferrite magnetic flux concentrators.
ii) Infrared absorption readout. Our team has pioneered an approach to diamond quantum sensing, based
on infrared absorption, that offers much higher sensitivity.
iii) Mitigating microwave phase noise. We are developing a dual-resonance approach that provides ~300x
suppression of microwave phase noise to reach our sensitivity goals.
In Phase I, we focus on Aim 1) Build a miniature flux-concentrator diamond sensor with infrared absorption
detection. Aim 2) Demonstrate a sensitivity of ~10 femtotesla for 1 second integration.

Public health relevance
ODMR Technologies, in collaboration with UNM, are developing millimeter-sized diamond quantum sensors for magnetoencephalography (MEG). These sensors can operate in Earth’s magnetic field and at ambient temperatures which enables close contact, ~1 mm, with a patient’s scalp and potentially removes the need of a magnetically shielded environment, expanding MEG access beyond elite hospitals.